MULTICENTER TRIAL OF ANA-756 IN PATIENTS WITH ESSENTIAL HYPERTENSION

Patients with essential hypertension are treated in double blind fashion a range of doses with the angiotensin II receptor antagonist ANA-756.